Impact of Interventions on Future Trends in Subnational Burden of Cardiovascular Diseases in the US

PROJECT SUMMARY
Geographic and racial/ethnic disparities in cardiovascular diseases (CVD) – the leading cause of death in the
U.S. – remain large. Since 2010, CVD death rates are no longer declining in many states, and for some
groups, mortality is increasing. Reduction in CVD disparities is a major stated goal of U.S. health policy, but
national-level strategies, such as Healthy People 2020 and the Million Hearts campaign, do not directly
address these large geographic differences in CVD between states. The U.S. is rich in local health data, yet it
is poorly integrated, so there is little evidence available to guide states or local health systems when selecting
among primary prevention interventions and policies. Health policy models are an important way to integrate
complex patterns of risk exposure and disease burden with other population trends including income,
education, aging, migration, and health care access. Previous CVD forecasts and policy models have
produced only single geography – primarily national – estimates, which cannot provide the evidence needed to
address geographic disparities. The overarching goal for this study will be: a systematic analysis of why CVD
patterns vary by age, sex, race/ethnicity, and state in the U.S.; how this variation will lead to future divergence
in CVD mortality rates; and the variable impact that similar risk reduction strategies will then have on different
U.S. states. For this work, we will adapt econometric, geospatial, and epidemiologic modelling methods by
leveraging the large data and computational resources of the Global Burden of Disease Study. Aim 1 is a CVD
population health projection that will estimate future burden of CVD for each U.S. state by age, sex, and
race/ethnicity. Using observed past trends in CVD and major modifiable causal risk factors, we will project
health loss due to CVD, including disability-adjusted life years (DALYs), through 2040 for each U.S. state. We
will integrate multiple sources of existing health surveillance data with the results of state-level health
examination surveys. Estimates will be produced separately by sex and 5-year age groups, for four collectively
exhaustive race/ethnicity categories for CVD overall, and separately for ischemic heart disease, heart failure,
stroke, peripheral vascular disease, aortic aneurysm, and chronic kidney disease. Aim 2 is a new set of CVD
health policy models that estimate the impact within each state of interventions shown to improve the delivery
of pharmacotherapies that lower blood pressure and LDL-cholesterol. Aim 3 is a new set of CVD health policy
models that estimate the impact of behavioral interventions shown to reduce CVD risk factors. Projections and
policy models for CVD are a necessary step in reducing U.S. health disparities. Our results will be able to
guide local decision-makers considering a range of policy options to reduce the burden of CVD. We will then
implement a broad dissemination plan designed to expand the impact of our work beyond academic
audiences, providing webinars, policy reports, and outreach to health departments and other stakeholders
actively engaged in policy work in key states.

Public health relevance
PROJECT NARRATIVE The proposed project is a systematic analysis of why the burden of cardiovascular diseases vary by race/ethnicity and state in the U.S., the extent to which this variation will lead to future divergence in mortality rates, and the variable impact that similar risk reduction strategies will have on different U.S. states. This project will build on the data and computational infrastructure of the Global Burden of Disease Study to: a) produce a new set of population health projections stratified by age, sex, and race/ethnicity, estimating the trajectory of cardiovascular diseases for the next 20 years in each U.S. state, and b) develop new health policy models that allow each state to examine the local impact of a broad range of interventions that improve cardiometabolic health. The results of this project will provide new evidence on the impact of interventions tailored to each U.S. state, allowing policymakers to improve their selection of policies that can reduce geographic health disparities.